MSC implantation as a treatment for developmental brain defects in craniosynostosis

PROJECT SUMMARY/ABSTRACT
Craniosynostosis is a craniofacial disorder, which is characterized by the premature fusion of cranial sutures with
the loss of mesenchymal stromal/stem cells (MSCs). Some craniosynostosis have neurocognitive deficits, which
are attributed to abnormally increased intracranial pression (ICP). However, the causes of ICP elevation and
brain defects in craniosynostosis are poorly understood. The goal of this proposal is to establish novel
mechanisms and a therapeutic strategy by which suture MSC implantation can lead to long-term reduction of
ICP and reverse neurological deficits in craniosynostosis. The scientific premise is based on our recently
published data (Cell, 2021, PMID: 33417861; Cell Stem Cell 2023, PMID: 37863055), in which we established
the first animal model of neurological defects in craniosynostosis, identified meningeal lymphatic vessel (mLV)
defect as a pathological driving factor for cognitive defects, developed a MSC-based suture regeneration
approach, and used this approach and successfully rescued brain structure and function defects in Twist1+/-
mice. This is significant because craniosynostosis is a major congenital disorder with a prevalence of 1 in every
2500 births. Previous animal research on craniosynostosis has mainly focused on skull dysmorphology, while
brain and neurological defects have largely been neglected. Current clinical practice in treating craniosynostosis
involves highly invasive complex surgery on calvarial bones at a very young age, with significant blood loss and
often requires repeated surgeries to prevent bone re-fusion. Our MSC-based treatment provides several
advantages over these practices, which include requiring only a single surgery at a focal cranial suture site with
minimal invasiveness, as well as the ability to reverse both skull and neurological defects. To truly enable clinical
translation, it is prudent to determine why MSC implantation has such robust benefits in correcting brain defects
in craniosynostosis. Preliminary data identified two potential risk factors for ICP elevation, including meningeal
lymphatic and cerebral vein defects. These defects might not be improved by the standard surgical operation in
current clinics but can be corrected by MSC implantation, which is the focus of this proposal. Overall, building
upon our strong preliminary data, this study seeks to provide the preclinical validation of MSC implantation as a
better therapeutic strategy over the surgical approach in current clinical practice for brain deficits in
craniosynostosis.

Public health relevance
PROJECT NARRATIVE Craniosynostosis is a craniofacial disorder with brain structural and neurocognitive defects. This proposal investigates how mesenchymal stem cell (MSC) implantation can mitigate elevated intracranial pressure and brain defects in craniosynostosis. The outcome will help develop an effective treatment for this devastating congenital disease.